Engineering IgG-specific endoglycosidases to selectively defeat effector functions

While IgG antibodies are critical components of the adaptive immune system and constitute an important and
growing class of drugs for the treatment of a wide range of diseases, they are also responsible for numerous
IgG-mediated pathologies. These include acute conditions, such as the antibody-dependent enhancement (ADE)
resulting from sub-neutralizing antibodies in severe dengue disease and severe Covid disease, and chronic
illnesses, such as autoantibody-driven autoimmune diseases. All of these IgG-mediated pathologies arise from
antibody-mediated effector functions, which themselves rely on the presence of N-glycans linked to the Asn297
residues on IgG Fc regions. Certain human pathogens secrete endoglycosidases that are absolutely specific to
Asn297-linked N-glycans on human IgG antibodies. Hydrolysis of these N-glycans results in a loss of Fc γ
receptor (FcγR) binding and renders these antibodies incapable of eliciting host effector functions; ultimately,
this provides the bacteria that secrete these IgG-specific endoglycosidases with a survival advantage. The best
characterized of these enzymes come from Streptococcus pyogenes, one of the most common human
pathogens, which secretes the IgG-specific endoglycosidase EndoS. In the previous award period, we elucidated
the molecular mechanisms by which this multi-domain enzyme specifically hydrolyzes IgG Fc region Asn297-
linked N-glycans to defeat antibody-mediated effector functions. We also discovered a novel family of single-
domain IgG-specific endoglycosidases from Corynebacterial species that are human pathogens. Furthermore,
we have shown that one of these Corynebacterial endoglycosidases prevents diverse IgG-mediated pathologies
in FcγR humanized mouse models, exhibits naturally low immunogenicity, and outperforms drugs currently used
in the clinic to treat IgG-mediated pathologies. Despite their therapeutic promise, we currently have an
incomplete understanding of how these enzymes function at the atomic level, which prohibits efforts to engineer
these enzymes to be selectively specific for subsets of IgG antibodies – a critical property for enzyme-based
therapeutics designed to treat IgG-mediated pathologies without fully immunocompromising the patient. Our
proposed studies aim to fill this knowledge gap by defining the molecular mechanisms by which this new family
of Corynebacterial IgG-specific endoglycosidases recognize both glycan and protein components of their IgG
glycoprotein substrates in order to modulate glycosylation, as well as to endow them with new substrate
selectivity properties in order to advance their therapeutic potential. To do so, we have assembled a highly
collaborative and complementary multi-PI team who have pioneered the understanding of IgG-specific
endoglycosidases and antibody-mediated effector functions. This work is significant because it will generate and
leverage mechanistic understanding of IgG-specific endoglycosidases to develop a range of therapeutic options
for difficult to treat IgG-mediated pathologies. The proposed studies are innovative in that they are the first to
advance the development of IgG glycoform-specific and autoantibody-specific enzymes.

Public health relevance
Many human diseases are the result of acute or chronic inflammation caused by antibodies that recognize either infectious agents, such as viruses, or human molecules in oneself, such as in autoimmune diseases. This antibody-mediated inflammation is dependent on a specific sugar molecule attached to the antibody. We propose to engineer enzymes that remove this sugar molecule from the antibody, rendering it non-inflammatory, to treat antibody-mediated diseases.